Institutional Training Grant in Pediatric Gastroenterology

Project Summary/ Abstract
This application is for the third renewal of the Institutional Training Program (T32) in Pediatric
Gastroenterology, Hepatology and Nutrition at the University of Colorado School of Medicine (CUSOM) and
Children’s Hospital Colorado at the Anschutz’s Medical Campus in Aurora, Colorado. The overall goal of our
T32 research training program is to provide a diverse group of post-doctoral trainees with an
exceptional supervised training and mentoring experience, to allow them to develop or enhance their
research skills, knowledge and grantsmanship in preparation for a successful pediatric
gastroenterology/ hepatology/nutrition- related research career. The underlying rationale for this program
is to take advantage of the strong physical and scientific synergies provided at the Anschutz Medical Campus,
an outstanding committed and experienced research faculty, and a large pool of potential applicants. Two
pathways of research training are offered to produce Basic Laboratory Scientists or Clinical/ Translational/
Health Outcomes Scientists, leveraging the resources at CUSOM in basic, translational, clinical and health
outcomes-based research. Research training will be focused in four general scientific themes: Mechanisms of
Tissue Injury and Repair, Innate Immunity and Microbiome Research, Clinical and Health Outcomes Research,
and Stem Cell Biology and Regenerative Medicine. The T32 faculty includes 32 scientists with ~$47 million
dollars in grant funding and a highly successful training record. Basic research experiences are augmented by
graduate courses, seminars and multidisciplinary meetings. Trainees in clinical-translational or health
outcomes research will participate in the Master of Science in Clinical Sciences Graduate Program of CUSOM
and will leverage the infrastructure of the Colorado Clinical and Translational Sciences Institute. The research
training is designed to be a 2-3 year program, beginning in the 2nd year of subspecialty fellowship. Eligible
candidates are primarily drawn from the nationally recognized fellowship in Pediatric Gastroenterology, with the
potential for candidates in other disciplines including neonatology, nutrition and related basic science fields.
Fellows are provided a minimum of 80% protected time for research training in a mentored and structured
environment. The quality of the educational and research experiences will be closely monitored by the
trainees, mentors and Executive Committee, with defined metrics and ongoing improvement processes. Of the
28 trainees who will have completed the T32 training by 2019, 75% will have full-time academic positions and
are developing their research careers. The continuation of 5 training positions is requested.

Public health relevance
Narrative This Pediatric GI T32 Training Program is directly relevant to child health by training the next generation of physician scientists who will be essential to advance the care and improve the quality of life of children and adolescents with GI, hepatology and nutritional disorders. The investment in multidisciplinary bench to bedside research training in this Training Program will provide a foundation for the trainees to become the future leaders, researchers and mentors who will help guide the direction of GI, hepatology and nutrition in the future.